MicroRNA regulation of chronic inflammation during aging

)897(*9
:DA@;5 ;@8>3??3F;A@ D787DD76 FA 3E Q;@8>3??39;@9R ;E 3 D;E= 835FAD 8AD ?3@K 397 D7>3F76 5:DA@;5 5A@6;F;A@E 7 9
6;347F7E 53@57D 8D3;>FK 47DD3@F ;??G@7 D7EBA@E7E ?3K 47 >;@=76 FA ;@8>3??3FADK ?76;3F76 ?7F34A>;5 3@6
8G@5F;A@3> 6;EAD67DE 4GF ?3@K ?75:3@;EF;5 93BE 7J;EF ?A@9 D757@F>K 3BBD75;3F76 D79G>3FADE A8 ;@8>3??39;@9
3D7 ?;5DA*'E ?;*'E (@7 7J3?B>7 A8 I:;5: ;E F:7 3@F; ;@8>3??3FADK ?;* 3 I:7D7 I7 3@6 AF:7DE :3H7
E:AI@ F:3F ?;57 678;5;7@F ;@ F:;E ?;*' EG55G?4 FA 3 >;87 E:ADF7@;@9 5:DA@;5 ;@8>3??3F;A@ F:3F ;@HA>H7E 5>;@;53>>K
D7>7H3@F 5A?AD4;6;F;7E &AD7AH7D 67>7F;A@ A8 ?;* ;@ , 57>>E E;9@;8;53@F>K 7JF7@6E F:7 >;87EB3@ A8 ?;*
3 ?;57 I:;5: BA;@FE FA 3 H;F3> DA>7 8AD , 57>> 7JBD7EE76 ?;* ;@ F:;E 5A@F7JF ;@5>G6;@9 , 8A>>;5G>3D
:7>B7D ,8: 57>>E /7 :3H7 D757@F>K 7JB3@676 AGD 3@3>KE7E A8 F:;E 5D;F;53> BDA57EE 4K ;@H7EF;93F;@9 @AH7>
B3F:I3KE ;@ 39;@9 , 57>>E F:3F 3D7 D79G>3F76 4K ?;* 6GD;@9 ;@8>3??39;@9 K 5A@6G5F;@9 E;@9>7 57>> *'
+7CG7@5;@9 E5*' +7C I7 :3H7 ;67@F;8;76 F:D77 97@7 BDA9D3?E F:3F 3D7 5AG@F7D D79G>3F76 4K ?;* 3 3@6
?;* ;@ 3976 , 57>>E F:3F :3H7 @AF 477@ BD7H;AGE>K 7J3?;@76 ;@ F:;E 5A@F7JF ,:7E7 ;@5>G67 37DA4;5 9>K5A>KE;E
5:7?A=;@7 BDA6G5F;A@ 3@6 E7@7E57@57 3EEA5;3F76 E75D7FADK B:7@AFKB7 ++) 835FADE 66;F;A@3> BD7>;?;@3DK
63F3 EF7??;@9 8DA? ;@;F;3> 7JB>AD3F;A@ A8 F:7E7 B3F:I3KE :3H7 BA;@F76 GE FA 3 @AH7> 397 3EEA5;3F76
;@8>3??3FADK , 57>> EG4E7F ,33 57>>E F:3F ;E 2&$ 3@6 F:3F 7JB3@6E ;@ 4AF: ?;57 3@6 :G?3@E
3@6 F:3F ;E D79G>3F76 4K ?;* 3E76 A@ F:7E7 BD7>;?;@3DK 63F3 I7 I;>> 53DDK AGF F:7 8A>>AI;@9 D7E73D5: 3;?E
;@ 3@ 788ADF FA 93;@ EG4EF3@F;3> @7I ;@E;9:FE ;@FA , 57>> 67B7@67@F ?75:3@;E?E F:3F 6D;H7 ;@8>3??39;@9 3@6 F:3F
3D7 D79G>3F76 4K ?;*'E /7 I;>> 3>EA G@;CG7>K 7JF7@6 F:7E7 3@3>KE7E FA KAG@9 3@6 A>67D 36G>FE ;@ 788ADFE FA
FD3@E>3F7 AGD 8;@6;@9E FA :G?3@E ,9,7304, 9/, -:4*9054(2 752,8 5- 30# 04+:*,+ ' % *,228
+:704. 04-2(33(.04. ,9,7304, 9/, 352,*:2(7 (4+ 3,9()520* 3,*/(40838 :4+,72>04. 30#
-:4*90548 04 % *,228 +:704. 04-2(33(.04. ,9,7304, 0- %(( (4+ %-/ *,228 (4+ 9/,07 30# 2,;,28 04
52+,7 (+:298 *577,2(9, <09/ 3(71,78 5- */7540* 25< .7(+, 04-2(33(9054 048:204 8,48090;09> (4+ 3:8*2,
897,4.9/ /7 3@F;5;B3F7 F:3F F:;E IAD= I;>> G@H7;> =7K 57>>G>3D 3@6 ?A>75G>3D ?75:3@;E?E 4K I:;5: ?;*'E B>3K
B;HAF3> DA>7E ;@ D79G>3F;@9 >;87EB3@ F:DAG9: F:7;D ;@8>G7@57 A@ , 57>> ?76;3F76 397 67B7@67@F 5:DA@;5
;@8>3??3F;A@ E 3 D7EG>F F:7D3B7GF;53>>K 35F;A@34>7 F3D97FE I;>> 7?7D97 I;F: F:7 BAF7@F;3> FA >;?;F 397 3EEA5;3F76
:G?3@ ;@8>3??3FADK 6;E73E7E F:3F 5A@F;@G7 FA D3B;6>K 93;@ ;@ BD7H3>7@57 ;@ AGD EA5;7FK

Public health relevance
Project Narrative Chronic, low-grade inflammation is a contributing factor to most diseases associated with aging. However, the molecular and cellular mechanisms that regulate chronic inflammation are still being deciphered. We will determine how specific regulatory microRNAs function to control age-dependent inflammatory status through their regulation of T cell metabolism, recruitment of inflammatory myeloid cells, and control of senescence-associated secretory phenotypes, and our work will identify novel therapeutic targets to treat this harmful condition.